SPHINCTER OF ODDI FUNCTION IN HEALTH AND DISEASE

The purpose of this study is to evaluate if abnormal motor function of the sphincter of ODDI causes unexplained symptoms of upper abdominal obesity. During X-ray ERCP examination pressures will be measured from the sphincter of Oddi by a catheter. A synthesized hormone will be given intravenously to determine of the SO contracts instead of showing normal relaxation.